Genes, Education, and Gene-Education Interactions in Obesity and Mental Health

PROJECT SUMMARY Tackling obesity and depression is vital for population health, not least because they are associated with diabetes, heart disease, strokes, and suicide, which in turn led to the decrease in US life expectancy in 2015. One policy advocated by Healthy People 2020 to reduce obesity and depression is increasing educational attainment, as it is viewed as a fundamental cause of health disparities. As obesity and depression also have strong genetic bases, it is possible that education additionally improves population health by moderating the underlying genetic risk of being obese/depressed through gene-environment (GxE) interactions. GxE interactions occur when the effect of genetic risk varies across the environment. The influence of genetic predisposition towards the likelihood of being obese may differ by educational attainment. A college graduate with a high genetic risk of being obese may never be obese because education is associated with higher income affording the individual to eat healthier and having peers who are conscious about leading a healthy lifestyle. In contrast, a high school dropout with a high genetic risk is more likely to be obese because he/she has a low income, is more likely to consume fast food, and interacts with peers who are obese. The proposed project will apply econometric methods, instrumental variables and within-sibling comparisons, that use quasi-experimental variation in educational attainment to increase our understanding of causal relations of education, genes, and GxE interactions on obesity and depression. The use of quasi-experimental variation will, under certain assumptions, produce estimates that are not confounded by (i) the influence of unobserved factors that are correlated with education and health, (ii) reverse causality, (iii) gene-environment correlations, and (iv) population stratification, and these estimates can therefore be given a causal interpretation conditional on these assumptions. The specific aims are to estimate main effects of education, genetic risk, and GxE interactions on obesity and depression using (i) the Easter School Leaving Rule as a natural experiment in the UK and data from the UK Biobank, (ii) local factors in the individual’s county of residence near secondary school completion age (college availability, education expenditures, unemployment rate) as instruments for education in the National Health and Nutrition Examination Survey and the National Longitudinal Study of Adolescent Health (Add Health) datasets, and (iii) the sibling fixed-effects approach in the Add Health dataset. Overall, the project will provide a comprehensive array of results and new insights as we compare results from different methods, datasets, across different educational levels, and by gender. This application is in direct response to NIH PAR- 16-080 “Education and Health: New Frontiers.”

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because obesity and depression are major public health problems in the US. Both conditions have significant individual and societal costs. They are associated with other adverse health outcomes and behaviors such as diabetes, heart disease, strokes, and suicide, which in turn led to the decrease in US life expectancy in 2015. This research will make important contributions to our understanding of the relations between education and obesity, and depression, and how heterogeneities reflected in gene-environmental interactions shape those relations.